Exploratory Therapy for the Skeletal/Dental Phenotype in PHOSPHO1 Deficiency

+:DDF6 ?@?DA64:7:4 2=<2=:?6 A9@DA92E2D6 +&( 2?5 ( '*( ' 2C6 EH@ >2EC:I G6D:4=6D %-D 2DD@4:2E65
6?KJ>6D 4C:E:42==J :>A@CE2?E 7@C E96 AC@A6C >:?6C2=:K2E:@? @7 D<6=6E2= 2?5 56?E2= E:DDF6D !?24E:G2E:?8 >FE2E:@?D :?
E96 +&( 86?6 :? 9F>2?D 2?5 "&" :? >:46 =625 E@ 9JA@A9@DA92E2D:2 (( H9:=6 23=2E:@? @7 E96
%(& % 86?6 :? >:46 =625D E@ @DE6@>2=24:2 7C24EFC6D 2?5 62C=J @?D6E D4@=:@D:D +96 D:>F=E2?6@FD 23=2E:@? @7
"&" 2?5 %(& % =625 E@ 6>3CJ@?:4 =6E92=:EJ 492C24E6C:K65 3J 4@>A=6E6 23D6?46 @7 D<6=6E2= 2?5 56?E2=
>:?6C2=:K2E:@? +96 D:8?:7:42?46 @7 +&( 7@C 3:@>:?6C2=:K2E:@? 92D 366? 6IA=@:E65 E96C2A6FE:42==J 'FC =23@C2E@CJ
92D 4@?EC:3FE65 >F49 @7 E96 AC6 4=:?:42= 52E2 G2=:52E:?8 >:?6C2= E2C86E65 +&( 2D7@E2D6 2=72 7@C E96 EC62E>6?E
@7 (( 2?5 2AAC@G65 :? 7@C A65:2EC:4 @?D6E (( *:?46 @FC 56>@?DEC2E:@? E92E ( '*( ' 567:4:6?4J :?
>:46 2=D@ =625D E@ 2 D@7E 3@?6 A96?@EJA6 ?@E F?=:<6 (( 2 A2E:6?E H:E9 ( '*( ' >FE2E:@?D 5:DA=2J:?8 ((
=:<6 DJ>AE@>2E@=@8J 92D 366? :56?E:7:65 &@ EC62E>6?E 92D J6E 366? 56G:D65 7@C E9:D AD6F5@ (( D<6=6E2= 56?E2=
5:D62D6 2?5 :? E9:D 9:89 C:D< 9:89 C6H2C5 ) 2AA=:42E:@? H6 AC@A@D6 E@ 6IA=@C6 E96 A@E6?E:2= E96C2A6FE:4 FD6 @7
>:?6C2= E2C86E65 +&( E@ :>AC@G6 E96 D<6=6E2= 2?5 56?E2= A96?@EJA6 :? @FC >FC:?6 >@56= @7 ( '*( '
567:4:6?4J

Public health relevance
Project Narrative (Public Health Relevance) Hypophosphatasia, a rare heritable disease caused by low alkaline phosphatase levels and characterized by soft bones, has become treatable by enzyme replacement In this proposal we will explore the potential efficacy of alkaline phosphatase replacement on a novel disease that presents features reminiscent of HPP but caused by a deficiency in PHOSPH01, an enzyme with distinct subcellular localization and function. The studies are exploratory in nature but if successful could lead to the repurposing of an established therapeutic principle for a new orphan disease as well as the optimization of a novel method of delivery of enzyme replacement that requires a single injection of an adeno-associated viral vector rather than multiple weekly injection of a biologic.